Microbiome targeted nutrition to improve immune function during critical illness

Project Summary
Immune suppression and bone marrow dysfunction are ubiquitous among critically ill patients. Short
term, this places an already vulnerable population at additional risk of life-threatening infections. Long term,
immune suppression can persist in the form of chronic critical illness which significantly worsens functional
outcomes. There is a need to rescue immune function early in the care of critically ill patients to avoid
detrimental short and long term consequences of critical illness. Many studies have attempted to do this but
have generally failed, and targetable therapies are still lacking. This may be in part due to lack of consideration
about the integral role of the gut microbiome in regulating hematopoiesis and immune function.
Emerging research has identified fundamental links between immunity and the gut microbiome. An
onslaught of publications have shown the microbiome shapes the immune system at various stages, including
during hematopoiesis. Recent murine studies have illustrated antibiotic induced dysbiosis impairs
hematopoiesis and suppresses bone marrow function. Clinically, our group completed some of the first
genomic studies illustrating microbiota derangements in critically ill patients, likely as a result of liberal use of
antibiotics. In addition to antibiotics, most critically ill patients rely on enteral nutrition which shapes their
microbiome. Previously we have shown artificial enteral nutrition (AEN), the default and most commonly used
formula for patients requiring enteral nutrition promotes dysbiosis. In contrast, high fiber plant based enteral
nutrition is well tolerated, promotes the growth of healthy commensal gut anaerobes, and improves outcomes
in murine models. In this proposal, unpublished data demonstrates PBEN is superior to AEN in mitigating ABx
induced lymphopenia, anemia, and neutrophilia. We also provide evidence that critically ill patients randomized
to PBEN have higher lymphocyte and lower neutrophil counts than those that received AEN. Still, how
antibiotics and diet shape hematopoiesis after ABx induced bone marrow suppression has never been directly
tested. Here, we will test the hypothesis that PBEN expedites immune recovery from antibiotic-induced
bone marrow suppression via repopulation of the gut with SCFA producing commensals that mitigate
myeloid skewing by 1) evaluating if PBEN is superior to AEN in restoring steady state balance between
myelopoiesis and lymphopoiesis in the bone marrow during recovery from ABx induced bone marrow
suppression and 2) testing the hypothesis that expedited immune recovery from ABx induced bone marrow
suppression with PBEN is mediated by microbial production of short chain fatty acids. Completion of these
aims will highlight nutrition as a previously underappreciated therapeutic target for improving immune recovery
of critically ill patients.

Public health relevance
Project Narrative There is a clinical need to support immune recovery in critically ill patients whose bone marrow dysfunction and immune suppression often lead to poor short and long term outcomes. Emerging evidence shows a critical role of the gut microbiome in controlling hematopoiesis and regulating immune function, therefore enteral nutrition can be therapeutically relevant strategy to modulate the microbiome and support immune recovery. Given our previous work utilizing murine models of antibiotic induced bone marrow failure, we hypothesize that plant based enteral nutrition will provide superior recovery from antibiotic-induced bone marrow suppression via microbial fermentation of dietary fiber and production of SCFAs compared to widely adopted artificial enteral nutrition.